ITCA Administrative Core

Administrative Core Abstract
Since its establishment in 1975 as a non-profit organization, the Inter Tribal Council of Arizona, Inc.
(ITCA) has advocated for self-determination for its Member Tribes through public policy development,
research, and education. The membership of ITCA is comprised of leaders from 21 federally
recognized tribes in Arizona.
ITCA operates more than 30 projects and employs a staff of 70 to provide technical assistance and
training to tribal governments in program planning and development, research and data collection,
resource development, education, health, management and evaluation. Strengthening tribal
governance is at the core mission of ITCA including taking action on matters that affect Member
Tribes individually or collectively and promoting tribal sovereignty.
The University of Arizona and the Inter Tribal Council of Arizona boasts a successful 20-year
partnership through the NARCH program in the American Indian Research Center for Health
(AIRCH). Our application for the Native American Research Center for Health XI (NARCH XI) focuses
on improving health disparities in our Tribes by strengthening tribal governance through research. We
propose four projects:
1. A capacity building project to develop the Arizona Tribal Research Review Board at ITCA to
serve tribes in Arizona who do not have the resources to establish their own review
process;
2. A graduate student career enhancement program to train an AIAN data science workforce
intimately knowledgeable about AIAN health issues and medical and public health
informatics;
3. A pilot project to understand environmental endocrine disruption, metal and antibiotic
resistance in bacteria, and wastewater epidemiology; and
4. A research project to elucidate the links between governance, health care, the environment
and community wellness.
The Administrative Core is critical to the success of the Center. It provides administrative, fiscal and
management oversight of all components and projects and guidance in evaluation and planning.
Process is key to the success of the Center and the Administrative Core provides the resources to
keep all elements of the Center functioning and moving forward and serves as a catalyst to engage
all the partners in regular and culturally respectful communication and relationship building.

Public health relevance
Administrative Core – Narrative The Inter Tribal Council of Arizona, Inc. (ITCA), is a tribally controlled non-profit organization established in 1975. ITCA has the goal of promoting American Indian self-reliance through public policy development, and to provide Member Tribes with the means for action on matters that affect them collectively and individually. The Member Tribes of ITCA are 21 federally-recognized Tribes located in the State of Arizona. The highest elected official of each Member Tribe serves on the council. These leaders have a comprehensive view of the conditions and needs of the tribal communities they represent. ITCA provides an independent capacity to obtain, analyze, and disseminate information vital to tribal community self-development. To build upon the ethical approach of research among the tribal communities, and continue a long- standing relationship with The University of Arizona in creating a space for developing AI/AN science focused students, ITCA proposes to provide the infrastructure for the Native American Research Centers for Health projects as the Administrative Core ensuring all rules and regulations of the award are delivered, along with efficient communication providing accountability of NARCH oversight.